HIV Drug Resistance Database

PROJECT SUMMARY
HIV drug resistance (HIVDR) is a threat to the success of antiretroviral therapy (ART) and a major barrier to
the elimination of AIDS as a public health problem. Persons with HIV who develop virological failure during
ART are at high risk of developing HIVDR and possibly transmitting a drug-resistant strain to others, and
persons who are infected with a drug-resistant HIV strain are at high risk of developing virological failure.
Comprehensive, accurate, and publicly available HIVDR data are essential for population-based monitoring
of acquired and transmitted HIVDR, for the clinical management of HIV-infected patients, and for identifying
overall drug-development needs. A public database that curates, annotates, and disseminates the primary
data from HIVDR studies will make it possible to identify and characterize the HIVDR mutations most
relevant to surveillance, clinical management, and drug development, and it will expedite research into the
mechanisms of HIVDR and the predictors of response to the newest ARV regimens.
The Stanford HIV Drug Resistance Database (HIVDB) has provided a unique conceptual framework for
addressing data-intensive questions about the main molecular targets of HIV therapy: reverse transcriptase,
protease, and integrase. HIVDB’s sequence analysis programs have also become integrated into the
workflows of many research laboratories worldwide. This Research Resource project is designed to improve
HIVDB by (i) replacing the previous ad hoc approach to data recruitment with a sustainable systematized
approach; (ii) streamlining and automating many of its core functions; (iii) expanding the user base to target
the most pressing global HIVDR research questions; and (iv) establishing principles of governance for the
inclusion of data in HIVDB and access to data in HIVDB.
Specific Aims: (1) To create a sustainable resource that catalogs the extent and genetic mechanisms of
acquired and transmitted HIVDR. Accomplishing this aim will enable researchers to identify gaps in the
published literature, perform novel analyses, and discover new knowledge; (2) To regularly update the
knowledge base required for interpreting HIV genotypic resistance tests and other online HIVDR analyses.
Accomplishing this aim will establish standards that can be applied to the analysis of HIVDR data across the
many molecular epidemiological and clinical studies performed each year; and (3) To provide enhanced
support for national and international research collaborations by creating improved software clients and
APIs for accessing HIVDB and new open-source software for analyzing HIVDR data. Accomplishing this
aim will support researchers in using HIVDB to advance their research, promote public availability of data
from new HIVDR studies, and generate feedback to be used in developing additional HIVDR research tools.

Public health relevance
PROJECT NARRATIVE The increasing prevalence of HIV drug resistance is a threat to HIV treatment and prevention. An HIV drug resistance database that curates, annotates, and synthesizes the primary data from many studies will be an invaluable research resource to the many researchers performing drug resistance surveillance, managing persons with HIV, and discovering new antiviral drugs. The proposed project will advance research to combat the threat that HIV drug resistance poses to containing the HIV pandemic. !